Administrative Core

PROJECT SUMMARY / ABSTRACT
The Administrative Core will be responsible for providing scientific administration and coordination, fiscal
oversight, and administrative support for this Program. The Administrative Core will foster integrative and
interactive collaboration across three Projects and 2 Scientific cores. The Core will coordinate all Program
meetings, including Monthly Meetings, Biannual Program Meetings, and the Annual Scientific Advisory Board
Meeting, among investigators at Yale School of Medicine, Harvard Medical School, Rockefeller University, and
Beth Israel Deaconess Medical Center. The Core will coordinate all travel arrangements and meeting logistics.
The Core will oversee the Program-specific Microsoft Teams channel, which will be used for all essential
communication across all Program participants including virtual meetings, online chat, and data storage. The
Core will coordinate the administrative aspect of annual progress reports both scientific and fiscal. The Core
will liaise between the grant offices of each institution. Dr. Chris Olsen will direct the Administrative Core with
Co-Director, Dr. Medzhitov. They will be supported by Carlos Bosques, Ph.D., who will serve as Scientific
Advisor, John Walter who will function as Administrative Director, and lastly Julie Henry, M.S. will serve as
Grants Manager. The Core has assembled two advisory committees for this Program. The Internal Advisory
Board will monitor progress, enhance collaboration, introduce novel technologies and techniques, ensure
quality control, and advise Program and Core PIs on factors such as experimental design and long-term
strategic planning. The Scientific Advisory Board will monitor progress and ensure that scientific goals are
being met during annual scientific review meetings.